Small molecule inhibitors targeting the SARS-CoV-2 pathogenicity factor Nsp1

SUMMARY
The COVID-19 pandemic has caused great harm to human life and the worldwide economy. Almost 2 years after
the emergence of its etiological agent SARS-CoV-2, there are still very few available antiviral drugs. The situation
is further aggravated by the emergence of new viral variants that might render available antiviral therapeutics
and vaccines less effective in the future. This calls for the development of diverse antiviral strategies, aimed at
targeting as many different viral pathways as possible. Here we explore for the first time the possibility to create
inhibitors of the viral protein Nsp1 to fight SARS-CoV-2 infection. Nsp1 is a major virulence factor that functions
by restricting host gene expression to inhibit antiviral signaling. We have recently identified nine putative
inhibitors of Nsp1 function by quantitative high throughput screening. We propose an in-depth structural and
functional characterization of the identified compounds to explore their capability to be developed into potent
antiviral drugs. In aim 1 we will use NMR spectroscopy to identify the pharmacophore and binding site(s) of the
small molecule inhibitors on Nsp1. It is the goal of aim 1 to determine the minimal ligand structural features
necessary for Nsp1 inhibition. We will also test commercially available analogs to interrogate which chemical
moieties can increase binding and inhibition. In aim 2 we will explore which functions of Nsp1 are targeted by
small molecule inhibition. By combining an array of complementary biochemical and cell-based assays, we will
interrogate the effect of small molecule inhibition on ribosome binding, mRNA degradation, and mRNA
translation. It is the goal of aim 2 to identify the mechanism of inhibition to aid future compound optimization. By
pharmacologically targeting selective functions of Nsp1, we might also gain new biological insight into the
coronaviral host-shutoff pathway. Overall, these studies should provide insight into the structure and mechanism
of potential small molecule inhibitors of SARS-CoV-2 Nsp1, laying the foundation for future chemical optimization
of lead compounds with the goal to develop new potent anti-coronaviral drugs.

Public health relevance
Project Narrative The COVID-19 pandemic’s catastrophic impact creates an urgent need for new and diverse antiviral strategies to fight SARS-CoV-2 infection and augment vaccines. We have identified nine putative small molecule inhibitors of the SARS-CoV-2 virulence factor Nsp1 using high throughput screening. The proposed project aims to structurally and functionally characterize these chemical compounds and thus provide the necessary foundation for the future chemical maturation of the small molecules into potent antiviral drugs.